Genetic Architecture of Alzheimer’s disease Proteinopathies

This is a collaborative study between leading experts in the field to extend our ongoing efforts to
delineate the complete genetic basis of the two AD-specific proteinopathies (Aβ and pathologic tau) by
whole genome sequencing (WGS) using well-characterized and large amyloid-PET and CSF Aβ42/tau
datasets with clinical outcomes of dementia followed by testing the effects of identified significant
variants on downstream neurodegeneration markers, and performing extensive bioinformatics and
functional studies. The primary objective of this application is to perform and analyze WGS in
adequately powered large discovery samples with well-characterized Aβ and tau data along with clinical
outcomes of dementia to identify putative functional variants associated with Aβ and tau pathologies.

Public health relevance
Alzheimer’s disease (AD) is a major public health problem. Currently there is no effective treatment for AD. Genetic studies aiming to improve our understanding of the pathogenesis of AD and underlying mechanisms may contribute to personalized medicine goals and better therapies and/or preventive measures This study is focused to delineate the genetic basis of two AD-specific proteinopathies, amyloid-beta (Aβ) and pathologic tau, by whole-genome-sequencing. The successful completion of the proposed comprehensive study using biomarkers of two AD-specific proteinopathies in living people with well characterized amyloid-PET and CSF Aβ42/tau datasets along with clinical outcomes of dementia followed by functional studies will make a major contribution to our understanding of the pathogenesis of AD and underlying mechanisms, which may contribute to personalized medicine goals and better therapies and/or preventive measures.